Elucidating electrical stimulation induced non-neuronal activity using emerging in vivo imaging technology and electrophysiology

Project Summary
Electrical microstimulation has become a mainstay of fundamental neuroscience exploration and an
increasingly prevalent clinical therapy. Despite the growing prevalence of neuromodulation therapies, the
fundamental physiological and mechanistic properties driving the beneficial effect for the patient are poorly
understood. This R01 application aims to greatly improve our understanding of how different non-neuronal
cells (myeloid lineage, oligodendrocyte progenitor lineage, and vascular smooth muscle cells) respond and
contribute to the electrical stimulation response. Understanding of the relationship between stimulation
parameters and supporting non-neuronal cell activity, including blood flow, will help determine the impact of
electrical microstimulation on chronic circuit behavior in-vivo over time. In this proposal, we use leading-edge in
vivo multiphoton imaging techniques with multiple transgenic animals to systematically evaluate the
relationship between stimulation parameters and the induced changes over time at the molecular, cellular, and
local network. An improved understanding of the impact of electrical microstimulation on the overall tissue
health, changes to the foreign body response, stimulation of tissue repair, and safety limits will help inform
improved stimulation paradigms and device design for therapeutic applications and basic neuroscience
research.

Public health relevance
Project Narrative This study characterizes the tissue response and safety limits of electrical micro-stimulation in multiple non- neuronal brain cells over time. Electrical stimulation is being used to probe brain activity and also treat a wide- range of diseases (e.g. Parkinson’s disease). A state-of-the-art imaging approach is proposed to guide the use of stimulation to induce changes in brain activity, including progenitor proliferation and differentiation.